Benchmarking the Sensitivity and Specificity of the Herringbone Microfluidic Device for Rare Particle Capture

PROJECT SUMMARY
Many new technologies are developed and validated on the bench of the investigator, but few have the
opportunity to test their performance with blinded, control samples. The lack of standards can be due to the
novelty of technology or processing conditions, or simply the uncertainly of the underlying biology within patients.
This is particularly challenging for liquid biopsy assays, as universal standards are desperately lacking, further
slowing down future translation to the clinic. Through our work with the RADx-Rad program, we have begun
validation testing for the parent technology featured in our R01 application: the ‘herringbone chip’, or EVHB-Chip.
The use of their blinded samples has been powerful, both validating our internal findings, while also catching the
attention of the regulatory agencies and other researchers. For this proposed study, we will conduct our most
complex validation panel yet, a full challenge panel to evaluate specificity and sensitivity of our assay, testing
over 100 blinded samples. This work will be done quickly, as we have all the tools and staff in place to test these
samples in one month’s time. We will have full data harmonization with the NIH DCC, to ensure consistency,
data standardization, and data deposits to the dbGAP database. Each sample is uniquely barcoded and the
contents will include a set concentration of nanoscale analytes for us to test with the concentration varying from
1x to 4x our limit of detection. Contaminating analytes are also added to these samples, to allow for specificity
to be determined. We will run each sample through our device, extract the RNA using our automated system,
quantify the amount of and types of RNA transcripts detected and share the data with the DCC. This will trigger
an automatic data unblinding, data transformation and analysis, allowing us to quickly assess device
performance. In addition to getting this critical device validation work completed, the resulting publication will
establish a new standard for diagnostic device development, which includes multi-party R&D efforts.

Public health relevance
PROJECT NARRATIVE Acceleration of diagnostic technologies requires rigorous processes and infrastructure to enable the rapid testing of system performance. For this study, we will test over 100 samples generated by a Laboratory Information Management (LIMS)-enabled procedure, allowing for our device to be benchmarked against a blinded challenge panel. The results of this work will yield a rigorously tested limit of detection, device sensitivity and specificity for the EVHB-Chip, the parent technology of our R01.